Dermal Drug Product Quality and Bioequivalence Assessment through Advanced MAM and PBPK Simulation

Abstract - Dermal Drug Product Quality and Bioequivalence Assessment Through
Advanced MAM and PBPK Simulation
The Office of Generic Drugs (OGD) is tasked with reviewing sponsor applications for dermal
dosage forms that purport to be bioequivalent to reference listed products for the same active
dosage forms. Sponsors need to have high confidence that the applications they submit for
dosage forms which are thought to be bioequivalent will receive favorable reviews. Software that
implements physiologically based pharmacokinetics (PBPK) and mechanistic absorption
modeling (MAM), and accounts for formulation effects in predicting local drug concentrations in
both the skin and systemic circulation can be a useful tool in reducing the time and expense
involved in designing new generic formulations by assessing their potential to be bioequivalent to
currently approved dosage forms by industry and regulatory scientists.
The proposed project will advance the state-of-the-art for dermal MAM/PBPK modeling in the
Transdermal Compartmental Absorption and Transit (TCAT™) MAM/PBPK model within the
GastroPlus® and MembranePlusTM software applications by incorporating more detailed
descriptions of (i) the temporal evolution of drug thermodynamic activity and transport in
formulations as their components are absorbed into the skin or lost to evaporation; and (ii) normal
and pathological skin physiologies; particularly as they relate to percutaneous permeation.
Specifically, we seek to add models for active metabolism and transport of drugs and pro-drugs,
binding to melanin and keratin, and enhancement of drug permeation by a formulation excipient
(chemical permeation enhancement). New formulation types (e.g. solid lipid nanoparticles and
nanostructured lipid carriers) will also be added to the TCAT™ model. Finally, the virtual
bioequivalence simulator in GastroPlus® will be expanded to more comprehensively reflect
formulation variability and skin physiological variability, and to include bioequivalence
comparisons of formulations based on local skin concentrations in addition to systemic
concentrations.
Advancing the state-of-the-art for dermal MAM and PBPK simulation requires a comprehensive
knowledge base to serve as the scientific foundation that talented scientists can apply in order to
develop useful equations and logic suitable for software; high-level computer programming skills
to encode the equations and logic into the software; and experienced scientists to test, validate,
document, and support the software for general use.
Throughout these efforts, we will maintain close contact with both the FDA and our collaboration
partners in order to ensure that the project team focuses on the software developments needed
for implementation of dermal product Quality by Design (QbD) and virtual bioequivalence
assessments according to the scope of the project.

Public health relevance
Project Narrative - Dermal Drug Product Quality and Bioequivalence Assessment Through Advanced MAM and PBPK Simulation The proposed project will advance state-of-the-art dermal mechanistic absorption modeling (MAM) and physiologically based pharmacokinetics (PBPK) modeling to provide a more complete and accurate model that can be used to inform decisions on generic dermatological product development and to advance the use of virtual bioequivalence (BE) assessments in regulatory decisions. This will be accomplished through a combination of expanding the existing knowledge base of skin physiology and mechanisms affecting the dermal drug absorption from a variety of formulations, and by implementing the enhanced models in the Transdermal Compartmental Absorption and Transit (TCAT™) MAM/PBPK model within MembranePlusTM and GastroPlus® software applications.